Adverse events reporting in Implementation science clinical trials

PROJECT SUMMARY
Our proposed work has the potential to develop differentiated, tailored adverse event reporting for
implementation science clinical trial designs, especially if the role and focus of reporting may not be
appropriately met using existing clinical trial adverse event reporting frameworks. Over the long term, these
benefits are intended to “trickle” down to all implementation science clinical trials in Africa and any other
parts of the world where efforts are required to ensure adequate and appropriate reporting of adverse
events in implementation science clinical trials. Our results will be presented at local policy and professional
development meetings, research meetings and international research such as journals and scientific
gatherings.

Public health relevance
PROJECT SUMMARY Our proposed work has the potential to develop differentiated, tailored adverse event reporting for implementation science clinical trial designs, especially if the role and focus of reporting may not be appropriately met using existing clinical trial adverse event reporting frameworks. Over the long term, these benefits are intended to “trickle” down to all implementation science clinical trials in Africa and any other parts of the world where efforts are required to ensure adequate and appropriate reporting of adverse events in implementation science clinical trials. Our results will be presented at local policy and professional development meetings, research meetings and international research such as journals and scientific gatherings. PROJECT NARRATIVE The application of implementation science principles to clinical trial methodologies in a relatively new field on the African continent. This project aims to define the current strategies in reporting adverse events in this new area and explore the limitations of current regulations in several countries within the sub-Saharan region. The impact of those limitations will be explored through a series of interviews and stakeholders’ meetings with key players in pharmaceutical industries, investigators, regulatory authorities, patients groups and funders of implementation science studies. This project aims to quantify the paradigm shift to develop appropriate policies to effectively regulate implementation science clinical trials in Africa.